Global post-transcriptional regulators in P. aeruginosa

Abstract
Pseudomonas aeruginosa is an important opportunistic pathogen of humans. It is the principal cause of
morbidity and mortality in persons with cystic fibrosis (pwCF), is a major cause of hospital-acquired pneumonia
and is particulary problematic in burn wound infections. Hfq is a conserved global post-transcriptional regulator
that is required for the virulence of P. aeruginosa. In other organisms Hfq is best known for its ability to promote
the base-pairing between small regulatory RNAs (sRNAs) and their target transcripts, with Hfq-promoted
interaction between an sRNA and its mRNA target typically functioning to repress target translation. Although
approximately 150 different sRNAs are thought to exist in P. aeruginosa, for most of these we understood little
about their possible regulatory roles because we did not know which transcripts they targeted. We have recently
identified the targets for approximately 90 Hfq-bound sRNAs in P. aeruginosa using an approach called RNA
interaction through ligation and sequencing (RIL-seq). These studies revealed that a single sRNA called PhrS
largely dominates the RNA-RNA interaction landscape in P. aeruginosa by pairing with close to 800 targets,
which is an unusually large number of targets for an sRNA. In Aim 1 we propose to use Ribo-seq to determine
which of the many targets of PhrS are controlled at the level of translation by this sRNA. We will also determine
whether the extensive target repertoire we observe for PhrS in one of the main laboratory strains of P. aeruginosa
is conserved in clinical isolates, where little is known about the regulatory roles of sRNAs. In Aim 2 we propose
to determine whether an sRNA called CrcZ, which acts as a molecular decoy for Hfq, functions as a global
regulator of sRNA-dependent control in P. aeruginosa. We will also determine whether putative base-pairing
interactions we have uncovered between CrcZ and specific sRNAs make them particularly sensitive to the
regulatory effects of CrcZ. Our study therefore has the potential to illuminate an additional mechanism through
which CrcZ acts. Finally, we have uncovered an sRNA that controls virulence gene expression in P. aeruginosa
and influences the ability of the organism to compete with another bacterial species. In Aim 3 we propose to
determine how this sRNA exerts its myriad regulatory effects. Our proposed studies might help explain why
mutations that abolish production of this sRNA occur in pwCF during the course of an infection. The experiments
described in this proposal are expected to reveal how three conserved Hfq-bound sRNAs exert key regulatory
effects in P. aeruginosa, and are relevant for understanding post-transciptional control exerted by sRNAs in
clinical isolates of this bacterium.

Public health relevance
Narrative Pseudomonas aeruginosa is an important opportunistic pathogen that is the principal cause of morbidity and mortality in persons with cystic fibrosis and one of the most common causes of ventilator-associated and hospital- acquired pneumonia. Our studies are expected to reveal how a global post-transcriptional regulator called Hfq, that is essential for the virulence of this organism, exerts its regulatory effects when working together with 3 small regulatory RNAs. This work has the potential to reveal novel therapeutic targets for the prevention and treatment of P. aeruginosa infections.